Involvement of microglial α7AChR in binge alcohol modulation of gut dysbiosis

Binge alcohol drinking is very common among the young people. Excessive alcohol consumption affects innate
immune signaling in the gut and the brain by altering gene expression and molecular pathways which lead to
alcohol use disorder (AUD). The binge alcohol-modulated gut-brain axis, retrogradely, is associated with
neuroinflammation and microglial activation. On the other hand, binge alcohol, anterogradely, may cause
neuroinflammation-mediated gut dysbiosis, via the “microglia-gut axis”. Targeting the neuroimmune system is a
new avenue for developing and repurposing effective pharmacotherapies and it is clinically relevant and highly
significant. The nicotinic alpha7 acetylcholine receptor (7AChR), which is expressed in microglia regulates
neuroinflammation through cholinergic anti-inflammatory pathway. Our published data and other study showed
that lipopolysaccharide (LPS)-induced inflammation releases pro-inflammatory cytokines and upregulates non-
functional 7AChR (futile) in macrophages and microglia. Stimulation of futile 7AChR with GTS-21 (7AChR
agonist), decreases LPS-induced TNF release in macrophages, and knockdown of 7AChR with 7AChR
siRNA in LPS-induced macrophages abolish GTS-21 beneficial effects. Our preliminary studies demonstrated
that mice given binge ethanol (EtOH) suffer with gut dysbiosis and continuously exhibit significant differences in
-diversity along with an increase in commensal proportions of Prevotellaceae family. Taken these premises
together, we hypothesize that binge EtOH exposure causes neuroinflammation and gut dysbiosis due to the
release of proinflammatory cytokines, which lead to microglial activation and increased expression of microglial
7AChR (futile), and bioinformatic analysis of these factors could establish a functional relationship among them.
In in vivo, disruption of microglia and microglial 7AChR utilizing PLX-5622 (microglia depletion reagent) and
microglial 7AChR conditional knockout (7AChRcKO) mice, respectively, will elucidate the discrete roles of
microglia and microglial 7AChR after binge EtOH exposure. The pharmacological intervention of GTS-21 in
vivo will reverse EtOH-induced effects on microglia activation, neuroinflammation and gut dysbiosis involving
7AChR. To test these hypotheses, we have posited two specific aims. Aim 1 is to characterize activation of
microglia, neuroinflammation and gut dysbiosis following binge EtOH exposure using C57BL/6J (B6) mice and
bioinformatics tools. Aim 2 is to elucidate the involvement of microglial 7AChR and role of microglia in alcohol-
modulation of neuroinflammation and gut dysbiosis by utilizing B6 and 7AChRcKO mice using PLX-5622 and
GTS-21. Our innovative project with high clinical relevance, might have high risk, yet very likely high reward.
Successful completion of this R21 project shall shift the paradigm from observing the gut-brain axis to
understanding and pharmacologically targeting the microglia-gut axis following binge exposure to EtOH and
would allow us to develop a full length R01 project to target the neuroimmune signaling in developing and
repurposing effective pharmacotherapies for alcohol drinkers.

Public health relevance
Project Narrative: This exploratory project will characterize the specific roles of microglia and microglial alpha7 acetylcholine receptor (7AChR) in neuroinflammation-mediated gut dysbiosis in C57BL/6J (B6) mice at different time points and delineate the mechanisms utilizing B6 and 7AChR conditional knockout (7AChRcKO) mice, an in vivo model of inflammation, and using GTS-21 (7AChR agonist) and PLX-5622 (microglia depletion reagent). Various datasets including RNA sequencng and 16S rRNA sequencing will be integrated and analyzed to identify possible causal correlation among expression and activity of microglial 7AChR, activation of microglia, neuroinflammation and gut dysbiosis. The data acquired from experimental outcomes will provide valuable molecular, cellular and genetic information pertaining to binge ethanol exposure on the microglia-gut axis, which will form a basis for translational studies in binge alcohol drinkers.